Modern Equipment for UMKC’s Shared-use Laboratory Animal Research Core Facility to Advance Biomedical Research-Related Operations

Project Summary / Abstract
The proposal requests funding for the purchase an modern animal cage and rack washer system with bottle
washing carts with rotary spray and universal basket rack for cages, as well as a cloud-based environmental
monitoring system for UMKC’s Laboratory Animal Research Core facility. The former is to provide the Laboratory
Animal Research Core facility with an advanced, environmental-friendly, high performing and high-throughput
system that will assist in and improve facility operations. As part of the high performing and high-throughput
system capacity of the system two bottle washing carts with rotary spray and two universal basket rack for cages
are being requested to facilitate higher staff and facility efficiency and reduce down-time of the system. The
proposed modern equipment will aid in the consistency and accuracy of animal care through improved
environmental sustainability and automation of animal facility operation. The latter is to provide the Laboratory
Animal Research Core facility with a cloud storage and web-based system to replace the current system that is
limited to a local server and can only be accessed in the office of the core director and not elsewhere in the core
facility or the institution. Further, it will enable core staff to monitor environmental conditions from any computer
improving both efficiency of operations and increased responsiveness to animal care needs and users, as well
as enable core staff to more effectively and quickly communicate with the university’s Central Facilities
Management team to control more readily environmental conditions. The modern equipment will enable
detection, measurement, monitoring, recording, and reporting environmental extrinsic factors to allow
experiments reproducibly conducted under similar environmental conditions and animal care, husbandry
settings. The novel and modern equipment will take advantage of existing resources while allowing core staff to
detect, monitor, quantify, record, analyze in real-time and report these factors and allow for the longitudinal
assessment of environmental factors, a capability that currently does not exist for the core and that a routine
upgrade would not be able to accomplish. The proposed systems will serve a diverse and increasing community
of NIH-funded researchers at UMKC meeting the current increased and future needs for biomedical research,
as well as modernize training in health-related research. The proposed equipment will accelerate research
progress and enhance the rigor, quality and breadth of research results and generate data of the highest impact
possible. Overall, these advancements will allow NIH-funded UMKC investigators active in biomedical research
conduct research on diseases that affect significant and increasing portions of the U.S. population including
minorities affected by disparities in health care delivery, to determine the underlying causes of human disease,
help design future therapeutics and improve health care.

Public health relevance
Project Narrative The proposal request funds to purchase an advanced, environmental-friendly, high performing and high- throughput animal cage and rack washer system and a cloud-based environmental monitoring system for UMKC’s Laboratory Animal Research Core facility. These state of the art systems are required to perform the most rigorous and quantitatively accurate experiments and is needed by NIH-funded scientists, who conduct research on diseases that affect significant and increasing portions of the U.S. population including minorities affected by disparities in health care delivery. Access to these systems will increase the impact of innovative research conducted by researchers by accelerating research progress and enhancing the quality and breadth of research results, determining causes, mechanisms of action and subsequently contributing to discovering potential treatment strategies and improving health care in major medical fields.